Hormonal contraceptive Access via Pharmacist-Prescribing Implementation package (HAPPI)

Project Summary/Abstract
With 95% of unintended pregnancies in the United States attributed to incorrect, inconsistent, or non-use of
contraception, improving access to reliable contraception is an important public health issue. Pharmacists are
considered the most accessible health care provider and are well-positioned to improve contraception access
by providing pharmacist-prescribed contraceptive services. The focus of this proposed work is on pharmacists
who can provide greatest access – those in community pharmacies. There are more than 67,750 community
pharmacies in the United States and only 3,500 are currently offering pharmacist prescribing of contraception.
In Phase I, we used a participatory approach to build a user-informed prototype of the Hormonal contraceptive
Access via Pharmacist Prescribing Implementation (HAPPI) toolkit comprising of a software application and a
web-based community of practice to support effective and sustainable implementation of pharmacist-
prescribed contraceptive services.
This Phase II project will use/apply user co-design and user experience (UX) design and research principles to
include end-users (i.e. community pharmacists and patients) in the development of the HAPPI toolkit. For the
HAPPI software application, we will develop and pilot the product in three phases guided by an adapted
version of Noorbergen et al.’s co-design framework for mobile health: 1) prototyping and development, 2)
evaluative, and 3) implementation. During the prototyping and development phase, we will gather feedback
from end-users via iterative usability testing and product enhancements. For the evaluative phase, we will bring
the HAPPI software into a single pharmacy to test how the product works in a real-world environment. For the
implementation phase, we will pilot the HAPPI software in several pharmacies using a single arm clinical trial
design to test the impact of the tool on service provision and patients’ access to care. In addition to the
software application, we will develop a web-based, professional Community of Practice (CoP) to disseminate
innovative educational content and technical assistance to support pharmacist-prescribed contraceptive
services, as a part of the HAPPI toolkit. Guided by the Reach, Effectiveness, Adoption, Implementation, and
Maintenance (RE-AIM) framework and Evidence-Based Quality Improvement (EBQI) approach, the content of
the CoP will be 1) developed and 2) implemented while undergoing iterative feedback collection from end-
users and refinement.
At the conclusion of this project, we will have a market-ready, proven, user-informed HAPPI software
application and toolkit that will facilitate the implementation of pharmacist-prescribed contraceptive services.

Public health relevance
Project Narrative With 95% of unintended pregnancies in the United States attributed to incorrect, inconsistent, or non-use of contraception, improving access to reliable contraception is an important public health issue and pharmacists are well-positioned to improve access via pharmacist-prescribed contraception services. This application builds upon the findings from Phase I to create a user-informed, comprehensive Hormonal contraceptive Access via Pharmacist Prescribing Implementation (HAPPI) toolkit comprising of a software application and a web-based professional community of practice to support implementation of pharmacist-prescribed contraception services. Principles of co-design, user experience (UX) research and design, and a clinical trial will be used to ensure the end product is proven, useful, market-ready, and acceptable to end-users, and therefore set up for commercial success.